Targeting USP10 to regulate the DNA damage response in NSCLC

ABSTRACT
Combating platinum resistance remains a daunting challenge in the treatment of lung cancer. Activation
of the cellular DNA damage response (DDR) is an important determinant of cell sensitivity to cisplatin and other
chemotherapeutic drugs, which eliminate tumor cells through induction of DNA damage and checkpoint
activation. We have recently found that histone deacetylase 6 (HDAC6) may promote degradation of a key DDR
protein, checkpoint kinase 1 (Chk1). The G2 cell cycle checkpoint is activated upon DNA damage in a Chk1-
dependent mechanism, and prolonged G2 arrest could lead to apoptosis. We have also found that a
deubiquitinating enzyme (DUB), ubiquitin-specific peptidase 10 (USP10), could stabilize HDAC6. Our group is
the first to discover HDAC6's ubiquitin E3 ligase activity, but targeting HDAC6's E3 ligase activity
pharmacologically is not currently possible. Therefore, we propose targeting USP10 to decrease the protein level
of HDAC6, which in turn induces persistently high levels of Chk1 to activate a prolonged G2 checkpoint arrest
upon cisplatin treatment, leading to apoptosis. Because the role of USP10 in cancer is context-dependent, we
searched the TCGA databases and found that a high level of USP10 is associated with shorter overall survival
(OS) in a subset of NSCLC with TP53 mutations from a cohort of ~1,000 NSCLC patients, indicating that USP10
may serve as an oncogene in this subset. Consistently, our preliminary data have shown that depletion of USP10
in TP53 mutant NSCLC xenografts drastically inhibits xenografts' growth and sensitizes them to cisplatin,
indicating an oncogenic role for USP10 in this subgroup of NSCLC. Reports from other groups as well as ours
have shown that HDAC6 stabilizes oncogenic mutant p53 (mutp53) and confers cisplatin resistance in NSCLC.
Based on our preliminary data and the literature, we hypothesize that the USP10-HDAC6 axis down-regulates
DNA damage response protein Chk1 to compromise the cell cycle checkpoint, leading to cisplatin resistance.
Thus, targeting this axis would activate the checkpoint and destabilize oncogenic mutp53, which ultimately
increases responsiveness to cisplatin and prolongs overall survival in NSCLC patients with TP53 mutations. To
test this central hypothesis, we will first explore the mechanism by which the USP10-HDAC6 axis confers
cisplatin resistance; we will then test the therapeutic potential of USP10 inhibition in treating TP53 mutant NSCLC
and evaluate a correlation between USP10 expression and cisplatin response, as well as a correlation between
expression of USP10's substrates and cisplatin response in a cohort of TP53 mutant NSCLC samples. The
outcome of our proposal will establish the oncogenic role of USP10 in the mutp53 subset of NSCLC and provide
a strong rationale for the development of clinically relevant USP10 inhibitors to treat this subset of NSCLC
patients, thus improving cisplatin responses and overall survival.

Public health relevance
PROJECT NARRATIVE The proposed research is highly relevant to public health and the NCI's mission. Our study, for the first time, has identified an oncogenic role for a deubiquitinating enzyme (DUB), ubiquitin-specific peptidase 10 (USP10), in a subset of non-small cell lung cancer (NSCLC) with TP53 mutations. Moreover, we propose a novel “USP10-HDAC6-Chk1-platinum resistance” axis in NSCLC, suggesting that USP10 plays an important role in the DNA damage response and checkpoint activation. The outcome of this project will provide a strong rationale for targeting USP10 in the TP53 mutant subgroup of NSCLC.